Quality of Medication Treatment for Opioid Use Disorder in Medicaid-enrollees: The Effects of State Policies and Intiatives

Project Summary
Opioid use disorders are a significant public health crisis, and medication treatment is the most effective
intervention for individuals with opioid use disorder. State policies and initiatives have increased medication
treatment utilization over the last decade, but increased utilization without attention to quality of care might limit
the public health benefits of medication treatment. Many states have begun implementing policies and
initiatives to improve quality, although with little empirical support of their effectiveness in real world settings.
This project will characterize how quality care for Medicaid-enrollees receiving medication treatment for opioid
use disorder and related health outcomes have changed over time, overall, and among historically
underserved and high-risk populations. We will then examine the extent to which policies and initiatives that
increase access and those aimed at improving quality are associated with better quality of care and related
health outcomes, overall, and for historically underserved and high-risk populations

Public health relevance
Project Narrative This project will characterize how medication treatment (MT) use, quality, and related health outcomes for Medicaid-enrollees with opioid use disorders has changed over time, overall, and among historically underserved and high-risk populations. We will examine the extent to which state and federal policies have increased MT use, improved MT quality, and improved related health outcomes, overall, and for historically underserved or high-risk populations.